Acquisition of an automated crystal imager

ABSTRACT
Funds are requested to acquire a JanSci UVEX-PS600 imaging system to visualize, interpret, evaluate and
record crystallization experiments generated during high throughput screening to identify crystallization
conditions for our biological macromolecules. UTMB has seven dedicated protein crystallography groups, as
well as a User Facility that serves researchers using protein crystallography as a secondary technique. Our
researchers leverage structural biology to investigate targets involved in neuropsychiatric disorders,
infectious diseases, immune defense, cancer, and diabetes-related disorders, as well as basic biological
mechanisms. The targets span a wide range of proteins, protein:protein complexes, protein:DNA complexes,
protein:drug complexes, and viruses. Many of our targets are very challenging: for example, large multi-domain
macromolecules, ternary protein complexes, glycosylated proteins and specific protein:drug complexes so that
we often need to screen thousands of crystallization conditions before promising hits are found which can be
leveraged to grow crystals suitable for high resolution diffraction experiments. To enable structure
determination, as well as speed up and decrease the cost of crystallizing our targets, we need an imaging
system that can efficiently identify successful crystallization conditions. The system must 1) drive the
science forward by identifying crystalline vs amorphous protein precipitate, and protein vs salt crystals; 2) image
and evaluate thousands of different crystallization experiments with high resolution and high speed; and 3)
handle a very large amount of crystallization data from many different projects in a multi-user environment.
Currently, the structural biology groups at UTMB are generating ~1300+ crystallization plates per year
(and rising) supported by $15M in NIH funding (9 R01s). We have no access to a working crystallization
plate imager at UTMB. Acquiring a UVEX-PS600 system and CrystalDetect/WebView software from Jan
Scientific will enable us to image crystallization experiments efficiently and at high resolution using both visible
and UV wavelengths to identity promising crystals, and provide enough imaging capacity to work with 628
crystallization plates at a time without manual intervention. The new instrument will be housed in the recently
renovated Sealy Center for Structural Biology and Molecular Biophysics (SCSB) at UTMB, and will be supported
by the SCSB. A Ph.D.-level X-ray Facility Manager, fully supported by the SCSB, will oversee the system. A
steering committee composed of a mix of users, as well as arm’s length experts, will provide oversight of the
policies relating to access, training, and maintenance, and it will be overseen by an established advisory
committee. The UVEX-PS600 system will serve our investigators carrying out NIH-funded projects at UTMB that
involve structural biology; access will also be provided to users at the SCSB and new faculty to facilitate their
competition for NIH support. In addition, members of the Gulf Coast Consortium will have access to this
equipment through the SCSB to perform pilot experiments on a wide range of structural biology projects.

Public health relevance
PUBLIC HEALTH RELEVANCE Funds are requested to acquire a Jan Scientific UVEX-PS600 automated imaging system to visualize, screen and interpret crystallization experiments with high throughput. Acquisition of this instrument will not only permit the identification of successful crystallization conditions for our various biological macromolecules which are involved amongst others in neuropsychiatric disorders, infectious diseases, immune defense, cancer, diabetes, but also speed up and decrease the cost of determining their 3D structures.